Developing second generation SCID pig models: filling the gaps to improve translation of therapeutics in regenerative medicine

Project Summary/Abstract: The promise of stem cell therapies has not been fully realized, due in part
to a paucity of appropriate pre-clinical models. The pig is an excellent model of human biology, due to similarities
of size, physiology, and genetics, and in some cases may be superior to rodent models, which often fail to provide
data which effectively translates to human clinical trials. Thus, pig models that more accurately model humans
are critically needed to improve research outcomes of regenerative medicine therapeutics and maximize safe
translation to the clinic. As SCID pig models show promise in xenograft studies, this establishes further needs
for humanized pigs as second-generation models and improved methods to routinely rear immunodeficient pigs
for measurement of survival, safety, and potential efficacy of implanted therapeutic cells. We are focused on
generating such new knowledge and demonstrating SCID pig use in preclinical regenerative medicine research.
We have developed biocontainment facilities and protocols to raise Artemis (ART)-mutant SCID pigs. We
have demonstrated this model's significance through successful ectopic engraftment with human induced
pluripotent stem cells (iPSC) and human cancer cell lines, as well as survival of orthotopically transplanted
human skin. To improve the model, we mutated the Interleukin 2 Receptor gamma gene (IL2RG) in a male ART
null background. The ART null IL2RG null pig has the expected T-B-NK- phenotype, and we have successfully
demonstrated partial human immune system development in these ART-IL2RG pigs. Thus we have taken
pioneering steps to establish a pig SCID model, but improvements in xenograft safety/efficacy testing and
humanization remain prerequisites to harness these research models for translational medicine.
The specific objectives of this application are to a) validate SCID pig models for preclinical testing of cell and
tissue xenografts, b) use multiple novel humanization approaches to determine the extent of human
hematopoiesis in SCID pigs, and c) establish second-generation SCID pig model management protocols at
multiple biocontainment facilities. The rationale for the proposed research is that our outbred SCID pig may more
accurately reflect how proposed stem cell derived therapies will function in humans compared to mice. This
project is innovative because we will use an integrated approach to combine research on the model's xenograft
potential with research focused on protocols for improving the use of immunodeficient pigs, including
humanization methods. We expect that the successful completion of this project will create genetic resources,
data on xenograft and humanization rates, and associated animal procedures that will be highly desirable for
SCID based modeling for research on the safety and efficacy of stem cell therapeutics. These unique resources
are expected to have a significant impact in accelerating the translation of regenerative medicine research into
the clinic.

Public health relevance
Project Narrative The promise of stem cell-based therapies in regenerative medicine is not currently being fully realized due to the lack of appropriate pre-clinical large animal models. We propose to further develop immunodeficient pigs as pre-clinical animal models by testing their ability to grow induced pluripotent stem cells (iPSC) and iPSC derivatives, as well as test their ability to engraft human hematopoietic stem cells into the bone marrow to develop a human immune system. Advanced models such as these can be broadly used for testing safety and efficacy of cell- based therapeutics, cancer therapies, and the study of human-specific pathogens.